Integration of Research, Mentoring and Professional Skill Building for Master's Students to Bridge to a PhD Program in Biomedical Science

California State Polytechnic University, Pomona (CPP), the lead institution for this grant, is partnering with the
University of California, Riverside (UCR), the RO1 institution, in a Bridges Master’s of Science (MS) to the
Doctorate Program (2021-2025). The overall program goal is to increase the number of MS students from
underrepresented minority (URM) racial and ethnic groups, low socio-economic backgrounds and those with
disabilities successfully transitioning to PhD programs in biomedical research. There will be 4 Cohorts of 6 MS
students per year (24 students total). Each student will have a CPP Faculty Research Mentor (FRM), a UCR
FRM, a CPP Faculty Advisor (FA) and a UCR FA. Bridges students will have 2 years to complete their MS
research project at CPP, participate in research-related skills at both institutions, take a UCR course and conduct
a 10-week summer research internship at UCR. The grant objectives will be: a) students complete MS programs,
are accepted and make a successful transition to a PhD program; b) students increase research knowledge and
skills needed to become biomedical independent researchers; c) students increase confidence in preparedness
for PhD programs; d) students deepen awareness of biomedical careers; e) CPP-UCR partnership creates an
integrated support system, faculty development, and networking for students to succeed in PhD programs. Short
term outcomes will be: 1) completion of doctoral program within 5 years; 2) presentation and publication of their
research; 3) CPP expands STEM research collaborations with UCR, other RO1 institutions and STEM industries;
4) increase CPP and UCR support of URM students through research opportunities, and post-doctoral positions.
Long term outcomes will be: 1) Bridges support system is integrated and sustained at CPP and UCR; 2) STEM
careers are supported by students’ families; 3) gaps closed in preparation and professional representation of
diverse groups in STEM research; 4) barriers of difference removed to create an inclusive STEM community.
Each student will be matched and integrated into CPP FRM and UCR FRM labs, present research findings,
attend seminars, journal clubs, workshops and scientific conferences at both institutions. To enhance faculty
mentoring, the CPP and UCR faculty will participate in professional development workshops and, since most
faculty have limited industry experience while a majority of the new PhDs enter industrial positions, faculty will
be encouraged to do a 4-6 week residency in industry. In addition to student panel discussions, Bridges students
will be paired with CPP MS alumni or UCR PhD predoctoral candidates to provide near-peer mentoring.
Leveraging these activities will build student confidence, communication skills, scientific ethical behavior, STEM
networking and awareness of future career opportunities. Sense of community will expand further by inviting
students’ families to program socials at the beginning, middle and end of the program to engage family. By
nurturing a sense of community amongst the Bridges students, their mentors, and their families, the students will
have a strong support network to help them complete a PhD and have a successful STEM career.

Public health relevance
By increasing the number of individuals who obtain PhDs in biomedical research, from groups that are under-represented in this field, the diverse communities in which these individuals have grown up, will have new role models for their following generations. As a PhD scientist, these individuals will have the credibility and background to be able to communicate effectively to these communities about how important biomedical research is to making discoveries that will enhance their own health, reducing illnesses and lengthening lifespan, as well as contributing to the overall health of our society.